Molecular Basis of Ecdysteroid Action in the Mosquito

Abstract:
Hematophagous female mosquitoes transmit numerous devastating diseases, while feeding on
human blood. A large enough blood-meal is essential for the development of eggs in a female
mosquito, thereby interlinking reproduction, blood-feeding and pathogen transmission. Therefore,
a clear understanding of the molecular mechanisms regulating egg development can play a
critical role in advancement of mosquito control methods. In Aedes aegypti, the Dengue-, Zika-
and Yellow fever- transmitting mosquito, two major insect hormones - the juvenile hormone (JH)
and the 20-hydroxyecdysone (20E), control the biphasic female mosquito reproductive cycle. The
post eclosion (PE) or the pre-vitellogenic maturation phase is under the control of JH, a
sesquiterpenoid. Whereas, the post blood meal (PBM) or the vitellogenic phase is mostly
controlled by the ecdysteroid, 20E. Some aspects of the molecular basis of JH action has been
deciphered in recent times. However, studies on the role of the intermediate factors within the
JH/Met regulatory cascade, are ongoing. Gene activation by JH, in most cases, is mediated by
direct DNA binding of the JH-receptor Methoprene-tolerant (Met). However, the repression
mechanism by JH is indirect, through intermediate factors. This proposal is aimed towards further
elucidation of the JH mediated gene activation and repression cascades. Investigation of the role
of Krüppel homolog 1(Kr-h1), as a downstream factor of Met in mediating gene repression, and
its cooperative action with the long-range repressor Hairy, will be one of the primary foci. The
proposed comparative analysis of the chromatin landscapes of JH pathway target genes, should
determine the contributions of the components such as Met, Hairy and Kr-h1, on the chromatin
states of the target genes. Most studies, on the mechanism of 20E action, have focused on
positive gene regulation through the Ecdysone Receptor (EcR). This proposal, is aimed mainly at
deciphering the role of 20E and EcR in the previously unexplored area of negative gene regulation,
during the vitellogenic period. We plan to elucidate the mechanism of direct and indirect negative
regulation and identify co-repressor(s) and intermediate factor(s) of the 20E/EcR-mediated gene
repression pathway. This study should potentially lead to identification of targets that can either
be blocked or transformed to achieve reproductive control in female mosquitoes, thereby reining
blood feeding and pathogen transmission.

Public health relevance
Project Narrative: Mosquitoes transmit numerous catastrophic human diseases while blood feeding, which is essential for the development of their eggs. Our goal is to elucidate the genetic pathways, underlying hormonal action, in female mosquito reproduction. The understanding of the molecular mechanisms controlling egg maturation is imperative for the development of mosquito control methods, in future.